University of Colorado Cancer Center Support Grant - CTRAC Supplement Yr 02

Project Summary / Abstract The conduct of clinical research is essential to improving the treatment options of cancer patients. Many treatment protocols are complex and prescribed using electronic health record systems where the treatment protocol orders have been built previously. The work of building these treatment protocols is a complex process involving many steps, substantial time, and can be the limiting step in opening clinical trials. Multi-arm and protocol amendments can be particularly time consuming to build. Unfortunately for multi-site clinical trials, this build process is duplicated at each site representing a lack of efficiency in the overall clinical research system. This project seeks to bring together a consortium of NCI-designated cancer centers who are leaders in both the conduct of clinical research and in clinical informatics, along with coordination with EHR companies, to establish standardized build conventions, develop means to make clinical trial protocol builds interoperable across sites, and ultimately to make the conduct of clinical research substantially more efficient. In this way we will be able to better leverage the power of clinical informatics systems to accelerate the conduct of clinical cancer research.

Public health relevance
Project Narrative Currently every center opening a trial is required to build its own trial calendar in its electronic health record (EHR) system. The focus of this supplement is to standardize the calendar build across multiple NCI designated cancer centers to increase the collective efficiency of opening trials. This will dramatically improve the timeline for trial opening, resulting in NCI Cancer Centers being able to deliver treatment options more quickly to patients. Additionally it will reduce cost for clinical research, enabling more research opportunities and at more locations outside of major academic centers.